RD HEPARIN VS PLACEBO TO PREVENT CORONARY RESTENOSIS POST PTCA

The purpose of this study is to determine if twice daily subcutaneous injections of RD heparin for three months will reduce the restenosis rate following initially successful PTCA.